Alzheimer's Disease and Related Dementias Innovation Incubator (InnovaTor)

PROJECT SUMMARY/ABSTRACT
Alzheimer’s Disease and Related Dementias (ADRD) are growing challenges to the public health and have
unmet needs that can be addressed through: Specific Aim 1) innovation and entrepreneurship; Specific Aim 2)
non-academic research-based careers; and Specific Aim 3) academic ADRD drug development. These three
themes will be developed in seminars, internships, lived experiences, discussions, and supervised projects of
the UNLV Brain Health Innovation Incubator (InnovaTor). The InnovaTor will be Co-Led by Principal Investigator
(PI) Jeffrey Cummings, MD, ScD, an experienced ADRD investigator and trialist and PI Jamie Schwartz, MBA,
Director of Industry and Business Engagement for the UNLV Office of Economic Development to create a
science-business leadership team. The InnovaTor will be a platform to help students identify research products
that have commercial value, protect intellectual property, initiate a start-up company, secure funding, promote
commercialization, and advance a marketing campaign (Specific Aim 1). The curriculum will include an
introduction to SBIR and STTR grant development. In addition to on-going seminars, a 1-week summer
Entrepreneurship Immersion Experience engaging UNLV students and others in discussions, projects, and team
exercises will be hosted by the InnovaTor. An annual Innovation Day will involve campus-wide activities to attract
participants to the InnovaTor and provide insights into the opportunities for ADRD-related entrepreneurship.
Discussions of non-academic career alternatives will be led by individuals with roles in government science
administration, advocacy, non-profit organizations, science writing and editing, policy think tanks, and investment
(Specific Aim 2). The InnovaTor has established a strategic alliance with Eli Lilly and Company to have industry-
based faculty interact with participants and educate about research-based careers in biopharma. Drug
development discussions will emphasize the academic-industry interface with associated start-up and
entrepreneurial opportunities (Specific Aim 3). An Innovator Club will be comprised of current and past InnovaTor
participants to encourage entrepreneurship and to support an evolving start-up community. An agile InnovaTor
structure will be supported by a Steering Committee, External Advisory Board, and an assessment team. Defined
milestones will guide the development of the InnovaTor. Outreach to UNLV programs as well as other
educational institutions in Southern Nevada will be led by an Innovation NavigaTor including a program to attract
undergraduate students (Pre-CubaTor). UNLV is both a Hispanic-Serving Institution and an Asian American
and Native American Pacific Islander-Serving Institution providing an opportunity to build programs to attract
minority students to InnovaTor activities. The InnovaTor will interact with NIH and NSF-funded programs at
UNLV, UNLV innovation resources (Lee Business School, Boyd School of Law, Office of Economic
Development), and local community biotechnology firms and organizations. The Brain Health InnovaTor will
build a culture of innovation and entrepreneurship devoted to ADRD.

Public health relevance
PROJECT NARRATIVE There are substantial unmet needs of patients with Alzheimer’s Disease and Related Dementias (ADRD) that can be addressed by advances in entrepreneurship, understanding of non-academic research-based careers, and promoting academic programs in the ADRD drug development ecosystem. The UNLV Brain Health Innovation Incubator (InnovaTor) will develop comprehensive programs including seminars, lived experiences, internships, and team projects focusing on these three themes. UNLV is a minority-serving institution and is committed to inclusive involvement of diverse participants from UNLV and other educational institutions in InnovaTor activities.